International Advancing genomics through the AMD Genomics Consortium (IAMDGC)

Age-related macular degeneration (AMD) is a leading cause of vision loss in older Americans and severely
impacts the independence, quality of life, and healthcare costs for those afflicted and their families. Genetic
variation has a major influence on AMD, but only about half of the heritability is currently understood.
Understanding the genetic architecture of AMD is critical for developing better treatments for AMD. The
International AMD Genomics Consortium (IAMDGC) has assembled 33 research groups and over the past four
years of this grant has enabled significant progress by extending the number of known risk loci and implicating
new biological pathways. This renewal extends these efforts to multiple genetic ancestries, study designs, and
more detailed phenotypic data. We propose the following aims:
1) Continue to expand the IAMDGC resource with new datasets. We have added seven new
collaborators and now have access to data from >100,000 participants.
2) Use universal hubs to process and share genomic, phenotypic, and biomarker data. Regeneron
Pharmaceuticals has agreed to conduct whole exome sequencing on approximately 40,000 participants at no
cost to the grant. By statistical imputation on the remaining GWASed samples, we will create an extremely large
dataset. We will continue to house the data in two analytic hubs (US and Europe) to simplify access and provide
computational and analytic support.
3) Perform detailed analyses on the extensive resulting dataset. The dataset (87,542 cases/controls
and 13,766 related individuals in nearly 6,000 families) enables testing of numerous genetic hypotheses
underlying clinical subtypes, biomarkers, effects of rare variants, and variability in the genetic architecture across
ancestries. The initial processing and analysis of the combined genomic data will be overseen through this
application and results will be available to all members. We have an efficient process allowing members to
propose additional studies and the broader research community to access these data and computational and
analytical support through the appropriate analytic hub.
4) Support the logistics and administration of the IAMDGC. Successful collaboration requires constant
communication and support. We will continue our yearly IAMDGC-specific face-to-face meeting, a second half-
day meeting for those attending the ARVO annual meeting, and regular teleconference calls.
Our goal is to greatly advance the understanding of AMD pathophysiology (using genomics as our
foundational guide) and thus speed the development of better treatments and/or preventions of AMD.

Public health relevance
NARRATIVE Age-related macular degeneration (AMD) is the most common cause of severe vision loss among older individuals. Variations in multiple genes strongly affect the risk of developing AMD but a substantial portion of the genetic architecture of risk, progression, response to treatment, and in different genetic ancestries remains unexplained. The International AMD Genomic Consortium (IAMDGC) addresses these gaps and seeks to develop a complete understanding of the genetic underpinnings of AMD as a pathway to better treatments and preventions.